Differential Regulation and Roles of A-type Lamins in Early G1

SUMMARY STATEMENT
Our funded work focuses on the role that lamin A (laA) and lamin C (laC) play in
genome re-organization and nuclear function as cells exit mitosis and enter early G1. A-
type lamins and their interacting proteins have been implicated in a range of diseases,
including premature aging, muscular dystrophy, cardiomyopathy, and cancer (among
others). The nuclear lamins (A- and B-type) form a meshwork underlying and interacting
with proteins of the inner nuclear membrane (INM). The proteins of the nuclear lamina
and INM are important for the 3D structure of the nucleus, scaffolding of the genome
and regulation of key cell type specific genes, DNA repair, nuclear envelope integrity,
splicing, mechanosensation, and attenuation of signaling. LaA and laC are splice
variants encoded by the LMNA locus. LaA has a unique C-terminal tail that is absent in
laC, while laC has only six unique amino acids that differentiate it from laA, also at the
C-terminal tail. Because of the difficulty in specifically targeting the laC isotype, there is
a paucity of studies into the differential roles and regulation of laA and laC. Recent work
in our laboratory has shown that laA and laC display different sub-nuclear distribution
and dynamics after mitosis and into early G1. Our recent data further indicate that lamin
A and C have some non-overlapping functions, particularly at mitotic exit, a critical stage
of the cell cycle where the genome is reorganizing and the cell and nucleus are
rebuilding. In particular, we find that lamin C is uniquely required for higher order
organization of lamina associated heterochromatin and also nuclear envelope repair.
These data also suggest temporal and isotype-specific mechanisms of localization of
laA and laC from telophase to early G1, perhaps through post-translational
modifications (PTMs), and that this spatio-temporal regulation is important for their
function(s). In addition to directed proteomics and genome mapping strategies, our
funded proposal relies heavily on single cell imaging (live and fixed) in normal cells or in
cells that have had lamin and lamin associated proteins functionality disrupted. Given
the number of disease-causing mutations in these proteins it is vital to understand the
overlapping and distinct roles of laA and laC in dynamic genome regulation and nuclear
function.

Public health relevance
PROJECT NARRATIVE The dysregulation of A-type lamins has been implicated in a range of diseases, including cancer, cardiomyopathy, lipodystrophy, muscular dystrophy and numerous other laminopathies. Our proposed studies aim to elucidate mechanisms of temporal and spatial regulation of the two A-type lamin isotypes, lamin A and lamin C, during the cell cycle and uncover how this relates to their overlapping and independent roles in functional genome organization and other pathways. These mechanistic and regulatory insights will enable directed targeting of key regions of these proteins to facilitate therapeutic drug design.